Human otopathology without invading the cochlea imaged using optical coherence tomography and verified with novel histological technique

Abstract
The human cochlea is encapsulated and mostly embedded in bone. Within the cochlea, complex architecture of
delicate microstructures function to transduce sound vibrations into neuronal signals. Difficult access and internal
fragility have limited our knowledge of the natural anatomy of the human cochlea. Thus, much of our
understanding of human cochlear anatomy comes from processed histology. With this proposal, we will
determine the fresh natural structural anatomy of human cochleae and its functional mechanical motion in situ
from unfixed and fresh cadaveric specimens with the use of Optical Coherence Tomography (OCT), which can
image and measure the motion of fresh human cochlear structures in their natural state without invading the
cochlea. Here, we propose a coordinated study of human cochlear anatomy and pathology based on OCT
imaging and vibrometry of fresh (<30 hours postmortem) unfixed human cochleae in situ, and light
microscopy imaging of histology prepared from the same donor. We will use OCT to noninvasively image
and measure the motion of the cochlear partition through the round window in one ear (Aim 1). To better interpret
OCT images, we will advance a novel rapid histological method to process both the OCT-imaged ear and the
contralateral ear from each donor, and section them to obtain views of the same cochlear location as imaged
with OCT (Aim 2). Direct OCT and histology comparisons from the same donor will enable us to better identify
the extent to which OCT can visualize cochlear structures and quantify histological processing artifacts. Our work
will result in better understanding of fresh human cochlear anatomy, which will set the stage for future possibilities
and may have profound clinical implications. The ability to noninvasively image and identify cochlear
structures may enable us to identify and diagnose pathologies in patients that previously could only be
visualized with histology in postmortem tissue. Intracochlear imaging would be invaluable for the testing of
new pharmaceutical therapies, as the success of these drugs may require that baseline anatomical conditions
of the cochlea be met, such as the survival of supporting cells or a near-normal appearance of the organ of Corti.
With the future development of endoscopic OCT probes, our results could translate quickly to the clinic and help
to better identify pathology and select the therapy with the highest chance for success in patients.

Public health relevance
Project Narrative Our knowledge of human cochlear anatomy comes from histology, which includes distortion from its natural appearance. This proposal aims to understand the natural anatomy by noninvasively imaging and measuring the motion of fresh and unfixed human cochlear structures in situ using high-resolution optical coherence tomography in conjunction with a novel rapid histological processing technique. Our work will result in better understanding of fresh human cochlear anatomy of normal and pathological states and will assess the clinical potential of OCT to improve diagnoses and treatment of cochlear pathologies.